Making data accessible: a rebuild and expansion of BrainRNAseq.org

Project Summary
Big datasets are now a routine output for many studies. A corollary of this reality is the ever-growing need to
disseminate this information to other scientists, a feat that presents its own challenges. Over 7 years ago, we
found ourselves grappling with these very questions because we had generated a series of mouse and human
datasets that we felt would greatly benefit the glial (and greater neuroscience) community. After many iterations,
we developed a website called BrainRNAseq.org, a central source where other scientists could easily and
quickly access our data—whether they were browsing at home, or while walking down the poster aisle at a
meeting. Over time, this website has become a staple within our scientific community and currently garners over
250 users per day, with over 56,000 different users in the past 3 years alone. However, the site is in need of
back-end repairs to ensure its utility for the foreseeable future. In the first aim of this proposal, we will rebuild the
site while maintaining its user interface and adding user-requested upgrades. Our second aim is to build a free
application that will enable other creators to build similar sites with ease. Creators will need no coding
experience—only a .csv file with their data, and our application (Dataspectra 2.0) will provide a suite of simple
aesthetic options to construct a user-friendly website where others can explore and download their data. Finally,
to consolidate the growing number of datasets currently scattered across the web, we will create “Barreseq”—a
central repositiory for glial datasets where trainees and faculty and quickly apply filters (species, data type, age,
etc) to identify relevant datasets for their specific interests. We envision a paradigm in which data sharing moves
towards standardization. We want to build the tools necessary to lower the activation energy for individuals to
share their data, and to do so in a mechanism that is visually familiar and digestible to other users. We believe
that this will strengthen our scientific community, both in terms of generating stronger hypotheses, and in the
spirit of more easily sharing the valuable resources that everyone is producing.

Public health relevance
Project Narrative The proposed project will rebuild a highly used transcriptomic database (BrainRNAseq, commonly referred to as “the Barres Dataset”) to ensure that this data remains of use to the glial and greater neuroscience community. Additionally, we will build a new, free, web application that will allow any group to quickly upload their own datasets and create similar easy to explore websites for disseminating their own data. Our intention is to decrease the barrier for sharing big datasets within the community, and conversely, to add standardization, uniformity, and simplification for users to interact with data that currently exists.